Investigating the in vivo regulation of Dynein activity

The establishment and maintenance of polarity is a fundamental feature of eukaryotic cells. Molecular motors
within cells transport a variety of cargo including RNAs, proteins, vesicles, and organelles. The asymmetric
distribution of these cargos by motor proteins is the underlying basis of cell polarity. The focus of this
application is on the microtubule motor, cytoplasmic Dynein. Dynein is responsible for the transport of most
cellular cargo towards the microtubule minus-end. In the absence of cargo, Dynein has limited activity. Fully
activating this motor requires the multi-subunit Dynactin complex, and one of several activating cargo adaptors.
As suggested by their name, cargo adaptors link Dynein with cargo and are also required for stimulating the
activity of the motor. The majority of studies regarding the mechanism of Dynein activation have been
performed using in vitro single molecule experiments. By contrast, much less is known regarding how this
motor is activated in vivo and which cargo adaptors are critical for its activity. Addressing this gap is knowledge
is the focus of this application. The model that I propose to use for these studies is the well-characterized
Drosophila melanogaster egg chamber, the reproductive tissue of the female fly. Dynein is essential for the
proper maturation of the Drosophila egg chamber and oocyte, and numerous cargoes are known to be
transported by Dynein in this tissue. Thus, the egg chamber is an ideal model for examining the mechanism of
cargo adaptor mediated Dynein activation. Based on my preliminary results, I will test two hypotheses. In Aim
1, I will test the hypothesis that Bicaudal-D (BicD) is the primary activation cargo adaptor for Dynein in the
female germline. In Aim 2, I will test the hypothesis that in the absence of the cargo adaptors Hook or Ninein,
that BicD is able to functionally compensate for their loss.

Public health relevance
Defects in microtubule-based transport are associated with a range of neurological disorders. This proposal seeks to understand the molecular mechanism by which the minus-end directed microtubule motor, Dynein, is activated for motility in vivo by cargo adaptors.